Interrogating Neuronal Membrane Potential Dynamics with Optical Voltage Sensors

Project Summary/Abstract
The long-term goal of this project is to interrogate the dynamics of membrane voltage in the context of intact
brains with high spatiotemporal resolution. Optical methods to dissect neuronal activity promise to revolutionize
our understanding of the brain at the cellular and circuit level; however, our understanding remains incomplete
due, in part, to a lack of tools that can report directly on neuronal activity with sufficient speed and sensitivity.
We propose to use the power of molecular design and organic chemistry to develop and apply new optical tools
for monitoring membrane potential with unprecedented speed and sensitivity in intact brains and without
disruptive capacitive load associated with other classes of voltage indicators. We plan to exploit photoinduced
electron transfer (PeT) through molecular wires as a versatile platform for optical voltage sensing. We will build
a palette of colors for optical voltage sensing that extends into the near infrared regions of the electromagnetic
spectrum; we will create new voltage sensors with exceptionally high two-photon absorption cross sections for
use in thick tissue and intact brains; and we will explore methods for genetically targeting and localizing ultra-
sensitive fluorescent voltage sensors to neurons of interest. Throughout, development of molecular tools will be
closely wed to applications in neurons and tissues, and we will apply these tools to understand how membrane
potential dynamics change in both healthy and neurological disease states.

Public health relevance
Project Narrative The coordinated firing of millions of neurons in the human brain gives rise to the diverse set of experiences, emotions, thoughts, and sensations that make up the human condition. Despite the central importance of neuronal physiology to human health and disease, our understanding of this complex field remains incomplete due to a lack of tools that can reliably report on membrane potential. This proposed research will develop and apply new optical tools to study neuronal membrane potential in cells and in circuits.